Beacon Sensors and Telerehabilitation to Assess and Improve use of Devices (BeST-AID) for Low Vision

Project Summary or Abstract
The successful application of magnification devices for reading and daily tasks is predicated on their correct
use by individuals with low vision (LV). Barriers related to transportation, geography, and/or health-related
concerns often limit LV patients’ ability to attend several in-office training sessions as part of LV rehabilitation
(LVR) to optimize visual function with magnification devices. A promising solution is real-time videoconferencing
to provide telerehabilitation, involving remotely delivered LVR services by a LVR provider in-office to a patient at
home. Telerehabilitation for LV appears to be feasible and acceptable by both patients and LVR providers, with
preliminary evidence that its efficacy for enhancing reading ability may be similar to in-office LVR. However, it
has not yet been fully demonstrated whether telerehabilitation is at least as effective as in-office usual care for
LV follow-ups. This would be critical information to reassure LV providers that either modality is acceptable.
This NIH Diversity Supplement aims to provide a clinical research experience with related training for the
candidate with a doctorate in occupational therapy to become involved in the non-inferiority trial that we are
conducting. The primary goal of the non-inferiority trial is to determine the potential for telerehabilitation to
enhance visual ability by providing remotely-delivered LVR training to use magnification devices and/or visual
assistive mobile apps in comparison to in-office usual care LVR. This will provide an evidence basis for whether
the effects of two interventions are not clinically and statistically different from each other. In addition to the
optimized task-specific training component of the non-inferiority trial, the Diversity Supplement aims to evaluate
how enhanced intervention approaches (i.e., habit training and motivational interviewing administered by the
candidate) in both telerehabilitation and in-office settings impact participants’ acceptability and utilization of LV
aids.
Another aim in this NIH Diversity Supplement is to develop and implement a training protocol specifically for
visually impaired patients to improve their access to electronic health records and healthcare resources through
patient portals. We will evaluate the efficacy of the training provided by occupational therapists to enhance low
vision patients’ health literacy and independence with health management. This study will focus on the Epic
healthcare web-based and mobile app portals at ophthalmologic academic centers. We will evaluate visually
impaired patients’ proficiency with patient portal access and health literacy pre- and post-training, as well as
document any reoccurring barriers to accessibility. Based on our findings, we will develop and disseminate
deliverables to support patient portal access for low vision patients. We will collaborate with Epic IT leadership
by providing recommendations to resolve patient portal accessibility challenges and improve user experience
among low vision populations. We will also create resources (e.g., videos, guides) for low vision patients and
stakeholders to support training and access to electronic health records through patient portals.

Public health relevance
Narrative This NIH Diversity Supplement will provide a clinical research experience with related training for the candidate with a doctorate in occupational therapy to become involved in the funded non-inferiority trial (BeST-AID) of telerehabilitation versus in-office care for low vision magnification devices. Specifically, we will evaluate how enhanced intervention approaches (habit training and motivational interviewing administered by the candidate) in both telerehabilitation and in-office settings impact BeST-AID participants’ acceptability and increased utilization of visual aids. Additionally, we aim to develop, implement and evaluate a training protocol specifically for visually impaired patients to improve their ability to independently access electronic health records and healthcare resources through Epic patient portals at ophthalmologic academic centers.